Administrative Core

The overarching goal of ASPIRES is to accelerate delivery of youth suicide prevention interventions and services in clinical and community settings to rapidly reduce the rate of youth suicide. The overall goal of the Administrative Core (AC) is to ensure that the center’s integrated approach to developing and deploying youth suicide prevention interventions and practices is more impactful than any single study or collection of separate research project grants (i.e., the whole is significantly better than the sum of its parts). The AC will accomplish this goal by providing: (1) robust administrative and organizational structure to support all the projects and cores; (2) increased synergy across disciplines and work settings (research/clinical); (3) a platform by which pilot feasibility studies can be solicited, selected, implemented, and results disseminated to enhance feasibility of suicide prevention research projects and improve likelihood of future funding; (4) training in youth suicide prevention services and implementation research; (5) evaluation of center research activities and public health impact; (6) effective communication of findings to local stakeholders and national/international consumers; (7) provision of scientific data to inform suicide prevention practices and research methodology; and (8) planning for sustainability of ASPIRES. Specific Aims of the AC include: (1) Create an infrastructure that promotes strong oversight and coordination of all ASPIRES Center activities; (2) Support transdisciplinary training opportunities for scholars in early stages of independent suicide prevention careers and advanced collaborating scholars not currently focused on suicide prevention; (3) Evaluate ASPIRES progress and outcomes; and foster dissemination of research findings and datasets.

Public health relevance
The Administrative Core (AC) is crucial to the success of ASPIRES, its projects, and cores. The center would not be able to function efficiently and effectively without the services of the AC. The AC, in collaboration with the MC, will assure that the overarching goal of the center is carried throughout each project and core.